Novel Adipose Targeted Gene Therapy for Lipodystrophy

PROJECT SUMMARY
Lipodystrophy includes a heterogeneous group of disorders that are characterized by abnormal or
degenerative conditions of the adipose tissue. This rare and often underdiagnosed condition can be
partial/localized or generalized and is generally associated with metabolic disorders such as insulin
resistance, diabetes, hyperglycemia, hyperlipidemia, and other severe conditions. Lipodystrophy can be
congenital or acquired and can often lead to deadly consequences due to liver, kidney, and cardiac
complications. All forms of lipodystrophy have severe insulin resistance and very low leptin levels. Currently,
leptin replacement using Metreleptin is the only treatment of lipodystrophy. However, Metreleptin injections
at a dose of once or twice a day cost an average of $565,000 per patient/year and can have adverse side
effects. Zvelt therapeutics is developing a safe, efficient, and cost-effective therapy for the treatment
of lipodystrophy. This therapy is mediated by recombinant adeno-associated virus (rAAV) vectors that offer
long-lasting transgenic expression and low immunogenicity. Typically, when AAV therapies are delivered
systemically, the vast majority of AAVs are sequestered in the liver, with little expression in target tissues.
This effect causes a narrow therapeutic window, as systemic AAV must be dosed near toxic levels to attain
therapeutic benefits. To overcome these challenges, Zvelt will use a novel engineered AAV serotype
Rec2 that preferentially targets fat, coupled with a dual cassette platform that minimizes transgene
expression in the liver. Zvelt Therapeutics has already established the proof of efficacy of the Rec2/Dual
Cassette vector containing the leptin gene (Rec2-leptin) for correcting leptin deficiency, obesity, and
metabolic syndromes in mouse models. Zvelt’s platform has been demonstrated to express in the targeted
adipose tissue while restricting off-target expression in the liver in the mouse model. In this STTR Phase I
project, we will perform dose-finding and safety analyses of Rec2-Leptin in relevant lipodystrophy mouse
models towards validation of this innovation for the effective treatment of lipodystrophy.
In Phase II, we will address key technical aspects of product development and safety and efficacy studies in
larger animal models to obtain essential data to support IND application. This will pave the way for a first-in-
human clinical study to collect evidence on the safety and efficacy of the treatment for lipodystrophy.

Public health relevance
NARRATIVE Lipodystrophy, a rare and usually underdiagnosed condition that affects adipose tissues and manifests in various metabolic disorders has no definitive cure, with existing ones being costly and causing several adverse effects. Zvelt Therapeutics has developed an engineered AAV serotype coupled with dual cassette (Rec2/dual cassette) capable of specifically targeting adipose tissues and avoiding the liver, thus making it a safe and cost-effective treatment for lipodystrophy. This STTR project will focus on preclinical validation of the dosage and safety of this novel therapy in a murine model.